COLORADO CLINICAL NUTRITION RESEARCH UNIT

The broad goal of the Colorado Clinical Nutrition Research Unit (CNRU) is to better utilize our clinical and basic science nutrition research expertise in order to make nutrition t more reliable and effective component of future health care. Reflecting the strength of our research base, the theme will be nutrient utilization with three focus areas: obesity & diabetes; developmental aspects of nutrient utilization; and micronutrient utilization and function. Each focus area will include a continuum of research from the patient or healthy subject ot the subcellular and molecular levels. The Colorado CNRU consists of an Administrative Core and 4 Scientific Core Laboratories - Energy Balance, Mass Spectrometry, Metabolic, Cellular & Molecular Biology. Included within the Administrative Core are a Pilot & Feasibility Program, a New Investigator Award, a recruiter, a statistician, and a communications expert. The Colorado CNRU will greatly strengthen existing nutrition research programs by promoting collaboration, stimulating new research directions, providing otherwise unavailable cost-effective measurements and expertise, and providing an outstanding environment for trainees and young investigators.